SENSITIVITY OF TISSUE HEMOGLOBIN TO BLOOD MEASURED LACTATE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. We plan to measure 100 patients in the critical care setting and compare standard blood work assessments with DOSI-measured hemoglobin concentrations.